BESIPIRIDE HYDROCHLORIDE (HP749) IN PATIENTS WITH ALZHEIMERS

This is a placebo controlled investigation designed to evaluate the efficacy tolerance and safety of multiple doses of HP749 during six months of treatment in patients with Alzheimer's disease.